Microscopy and Microfluidics Core

PROJECT SUMMARY: MICROSCOPY AND MICROFLUIDICS CORE
The objective of the C-SiG Microscopy and Microfluidics Core (MMC) is to be a user-friendly resource
that connects investigators with state-of-the-art, optical and microfluidics technologies and services.
Under the direction of Dr. Mark McNiven, an accomplished cell biologist, and Dr. Alexander Revzin an
experienced biomedical engineer, the Core integrates existing resources with new equipment added during
this funding cycle (Zeiss LSM980 + Airyscan 2 and Nikon AXR confocal systems and microfluidic
devices). This Core also collaboratively partners with the Institution-wide Mayo Microscopy and Cell Analysis
Core to enhance resources available to center members by providing GI-relevant expertise and training for C-
SiG members. The Specific Aims of this core are three-fold. First, to provide reliable, accessible, state-of-the-
art microscopy and microfluidics technologies to C-SiG members to facilitate their study of GI cellular signaling
cascades. Second, to provide education, technical advice, guidance, and feedback on experimental design
and results for both basic and sophisticated cellular imaging and microfluidics methods. Emphasis is placed on
providing technical instruction as well as educating faculty on how such approaches can expand the scope and
breadth of their scientific programs. Third, to work collaboratively with C-SiG members to develop proficiency
in the use of cutting-edge optical imaging and microfluidics technologies that offer new capabilities for
assessing cell signaling. The most popular Core service is access to the well-maintained C-SiG
Microscopes (> 37,600 hours total during the past 5 years). The Core also provides consults, training,
technical advice, and development of novel, innovative optical and microfluidics approaches to the
study of signaling pathways in GI cells and tissues. Consults and training cover a wide range of topics
including: confocal, histology, live cell, total internal reflection fluorescence (TIRF) microscopy, and super-
resolution microscopy; microfluidics device design and applications; expression and use of fluorescence-based
bioprobes that facilitate the study and localization of specific signaling molecules including both proteins and
lipids; cell/tissue computer morphometry; high resolution real-time imaging of live cells, and data analysis. In
addition, the Core now provides full-service microfluidics support including device design, fabrication,
and execution of microfluidics experiments for C-SiG members. Since September 2019, when we began
piloting microfluidics services within this core, the core has provided 17 C-SiG members with 692
microfluidics devices, including those developed for spheroid/organoid culture, organotypic cultures,
paracrine and juxtacrine co-cultures, and neuro-epithelial co-cultures. Over the past 5 years, the C-SiG
Microscopy and Microfluidics Core has provided services to 66% of current membership and supported 103
publications.